Postdoctoral Research in Neurodevelopmental Disorders

DESCRIPTION (provided by applicant): This application, "Postdoctoral Research in Neurodevelopmental Disorders", is a request for five years of funding for the competing continuation of an NIH National Research Service Award (NSRA) Institutional Training Grant (T32). Recent advances in behavioral science, neuroscience and molecular genetics have led to dramatic gains in our understanding of the pathogenesis of neurodevelopmental disorders. The purpose of this training program is to develop researchers with expertise in both the biological basis and clinical manifestations of neurodevelopmental disorders. This broad-based and integrated perspective will enable researchers to better relate across disciplines and will maximize the potential for major research advances in understanding the pathogenesis and treatment of these disorders. The proposed postdoctoral training plan provides a variety of opportunities including: (1) mentored research training in specific methods, disorders and underlying pathogenetic mechanisms;(2) a range of didactic experiences (including courses, seminars and lectures) that integrate the study of clinical disorders, normal developmental processes, mechanisms of disease and research methods;and, (3) clinical exposures to complement previous levels of clinical experience. Twenty Ph.D. or M.D. level trainees (four new trainees per year) will participate in this two year training program, over the five year period of this application. This application addresses the critical need for focused training opportunities beyond formal graduate programs by using the existing interdisciplinary research and administrative structure of the University of North Carolina Neurodevelopmental Disorders Research Center (UNC NDRC), together with the excellent clinical and basic science resources of the University of North Carolina, to provide an ideal environment for integrating training in biological and behavioral research in neurodevelopmental disorders.